Investigation of active kinome networks in Alzheimer's dementia.

Summary
This is a revised R01 application from a team of established investigators who bring complementary expertise
for a multi-omics, hypothesis generating, series of experiments that have the overarching goal of deepening
understanding of the pathophysiology of Alzheimer’s dementia (AD). Taken together, the prevalence of this
devastating disorder, the paucity of efficacious treatments, and the very high failure rate of clinical trials for new
AD treatments indicate a pressing need to better understand how this disease breaks the brain. We posit that
measures of protein function, rather than gene expression, are needed to develop a more sophisticated
understanding of AD progression. Protein function can be measured in many ways. Genetic or
pharmacological manipulation provides compelling insights for causal relationships between proteins. Such
work relies on assumptions about biological function that are linear. However, the sum of the properties of
individual components may not model whole systems, and orchestration of complex systems may not be
explained by individual components. This is particularly true for protein kinase signaling, where overlap,
crosstalk, and reversibility of phosphorylation events makes for non-linear networks. In this proposal, we
embrace this complexity with a series of experiments designed to assess these typically non-linear networks.
We plan to assess the serine/threonine subkinome using an unbiased protein kinase activity array approach.
Combined with bioinformatics tools that yield protein kinase networks and nodes, we hypothesize that higher
order information regarding signaling networks in AD progression will yield novel insights about the disease.
The biological substrates for this study will include postmortem brain from control, mild cognitive impairment
(MCI), and AD subjects, as well as iPSC-derived neuronal, astrocyte, and microglia cultures from sporadic (late
onset) and familial AD cases. AD progression will be assessed with early, intermediate, and late timepoints in
AD iPSC cultures, and by comparing control vs MCI and MCI vs AD postmortem samples. Deliverables include
1) identification of protein kinases networks and nodes associated with AD progression, 2) validation of protein
kinase nodes during AD progression between and across postmortem and iPSC substrates, and 3)
advancement of validated protein kinase nodes for causal studies in human AD iPSCs. Effects of sex will be
assessed as a secondary outcome, with equal numbers of male and female samples for each AD substrate.
LCMS datasets will be generated in parallel to kinome array datasets, permitting multi-omics integration. All
datasets will be incorporated into an R-Shiny platform that integrates biological features of protein kinases.
Importantly, the preliminary data for this proposal demonstrate that this project is low-risk, high reward, as we
have performed a series of rigorous studies that identify candidate protein kinase network nodes and carefully
advance and validate a candidate node previously implicated in AD that has not been studied in human model
systems. For these reasons, we believe that this project is highly impactful with a high probability of success.

Public health relevance
Narrative The overarching goal of this project is to extend knowledge regarding the pathophysiology of AD progression to protein kinase signaling networks. Assessment of signaling networks will move the field beyond simple measures of gene expression, providing important insights for changes in protein function in the devastating and common disease.